CRYSTAL STRUCTURE OF FIV DEOXYUTPASE (DU)

DU is an essential enzyme of nucleotide metabolism. The structure of the E. coli enzyme has been solved, but is partly disordered and the active site is not visualized. Further, it is a trimer whereas the FIV DU is a dimer or tetramer.